Transportability Methods to Extend Inferences from Contemporary Type 2 Diabetes Clinical Trials to Veterans

Type 2 diabetes mellitus (T2D) is a common chronic disease associated with morbid and costly
complications, including cardiovascular disease and chronic kidney disease - together referred to as
cardiorenal complications. New medication classes - glucagon-like peptide-1 receptor agonists (GLP1 RA) and
sodium-glucose cotransporter-2 inhibitors (SGL T2i) - have proven cardiorenal benefits in individuals with T2D.
Veterans have a higher prevalence of T2D than the general population of US adults, and Veterans with T2D
have a higher prevalence of cardiorenal complications than non-Veterans with T2D. Thus, evidence in
Veterans with T2D regarding the effects of GLP1 RA, SGL T2i, and alternative glucose-lowering medications on
glycemia and cardiorenal complications may have substantial implications for VA T2D care. However,
Veterans are infrequently participants in influential randomized clinical trials (RCTs) of T2D medications,
creating a critical evidence gap: whether the results of RCTs of GLP1 RA, SGL T2i, and other glucose-lowering
medications are externally valid in Veterans with T2D.
The overall goal of the proposed study is to use biostatistical tools known as transportability methods to
project effects from recent RCTs of T2D treatment to Veterans with T2D and to evaluate the impacts of
different treatment policies on cardiorenal complications in Veterans and system-wide costs. The challenge of
assuming RCT results apply to potential real-world users of a medication who were not RCT participants is that
differences in baseline characteristics could modify the treatment effect observed in the trial, leading to invalid
inference of the treatment effect in the real-world population. Transportability methods re-weight individuallevel
RCT data to balance baseline characteristics between RCT participants and a target population - in this
case Veterans with T2D who meet RCT inclusion/exclusion criteria. Prior work from the investigator team has
demonstrated the validity of transportability methods across a range of data settings and shown that these
methods can accurately project treatment effects from one study population to a second. Transportability
methods, therefore, provide a statistical tool to address the evidence gap between RCTs and real-world care.
The proposal focuses on five recent RCTs in individuals with T2D: GRADE, CANVAS, EMPA-REG
OUTCOME, LEADER, and SUSTAIN-6. GRADE compared four medications as second-line treatment for T2D
in individuals with inadequate glucose control on metformin alone - a very common clinical scenario in the VA.
CANVAS and EMPA-REG OUTCOME examined cardiovascular and renal outcomes associated with the
SGL T2i canagliflozin and empagliflozin, respectively, the latter being the most commonly prescribed SGL T2i in
the VA. LEADER and SUSTAIN-6 examined cardiovascular and renal outcomes associated with the GLP1 RA
liraglutide and semaglutide, respectively - the two most frequently used GLP1 RA in the VA. Aim 1 will provide
effect estimates of GLP1 RA, SGL T2i, and additional glucose-lowering medications on glycemic and
cardiorenal outcomes based on these five RCTs transported to all trial-eligible Veterans with T2D. In Aim 2, the
target populations are narrowed to subgroups of Veterans based on age and elevated risk of cardiorenal
complications to gain insight into potential benefits of prioritizing specific subgroups of Veterans for treatment
with GLP1RA and SGLT2i. Aim 3 estimates the number of cardiovascular events prevented and VA systemwide
costs under different treatment policies - treat all eligible Veterans versus prioritizing specific subgroups.
This study is innovative in its application of emerging biostatistical tools - transportability methods - to
address a gap in actionable evidence between influential RCTs with few Veteran participants and comparative
effectiveness research studies in Veterans. Given the potentially broader applications of transportability
methods, the study is poised for lasting impact by providing an analytic roadmap and accompanying statistical
code and pipeline to facilitate the use of these methods in the VA in other disease/drug contexts in the future.
Project Summary/Abstract

Public health relevance
While new medication classes promise to transform diabetes care and reduce diabetes complications, there remains limited evidence of their effects in Veterans with type 2 diabetes. This is largely because Veterans are not well-represented in randomized clinical trials, and Veterans often differ from clinical trial participants across many clinical and demographic characteristics, exacerbating the challenge of generalizing trial results to Veterans. Recent advances in biostatistical methods offer tools for bridging this evidence gap between clinical trials and real-world patient populations. We propose to apply these methods, called transportability methods, to several recent clinical trials in type 2 diabetes to generate valid VA-specific evidence of the efficacy of contemporary diabetes treatments in Veterans. We will then use this real-world evidence in Veterans to project short-term impacts - the potential number of diabetes complications prevented, budget impact for the VA, and cost-effectiveness of different treatment strategies - that may inform VA diabetes treatment guidelines.